Core B - Functional Immunology Core (CIIG)

PROJECT SUMMARY/ABSTRACT
The overall objective of Core B: Host Immune Response Core is to provide comprehensive and
consistent immune monitoring for the Center for Immunological Interventions against Gonorrhea (CIIG). This will
help the Center to develop and characterize vaccine, therapeutic, and diagnostic candidates in a rigorous and
systematic manner. Core B will provide all Projects with centralized assays to evaluate immune responses
elicited by Neisseria gonorrhoeae vaccine and therapeutic candidates. The Core will also develop and validate
standardized assays for pre-clinical and clinical studies to position products on a feasible path for licensure by
the end of the five-year funding period. While doing so, the Core will help identify correlates, surrogates and
mechanisms of protection against gonorrhea. Thus Core B is critical to the success of the CIIG. To ensure
successful completion of the projects in the CIIG, Core B proposes the following Specific Aims. Aim 1: Humoral
and cellular immune response profiling: We will provide high-throughput evaluation of antibody quantity,
quality (avidity), and isotype profile in serum and mucosal washes after immunization. We will comprehensively
immunophenotype lymphoid and genital tract tissue following immunization and pathogen challenge, and we will
profile systemic and genital biomarker responses using multiplex arrays. Aim 2: Evaluation of protective
mechanisms: We will measure the serum bactericidal activity and opsonophagocytic killing activity of serum
and mucosal washes after immunization. We will monitor T cell activation by performing in vitro antigen
restimulation and analyzing by flow cytometry, FluoroSpot, and multiplex arrays. We will provide in vitro models
of human genital epithelial cells to evaluate N. gonorrhoeae colonization and inflammatory responses in the
context of immunization and novel therapeutics. Aim 3: Preclinical and clinical assay development and
validation: We will expand assays including multiplex antigen binding, serum bactericidal activity, and
opsonphagocytic killing to a panel of currently circulating N. gonorrhoeae isolates. Antibodies selected for lateral
flow diagnostics will be similarly tested for reactivity. Product-specific immunogenicity and efficacy assays will
be selected in conjunction with Core D to support product advancement through IND-enabling preclinical and
phase I/II clinical studies, in line with current NIH/DMID guidelines. Core B will work closely with the CIIG PI and
all Projects and Cores to ensure that the milestones of the CIIG are achieved in a rigorous, comprehensively-
documented, reproducible, and timely manner. In these ways Core B will help the CIIG identify vaccine,
therapeutic, and diagnostic leads for deployment to combat gonorrhea, a major antibiotic resistance public health
concern.

Public health relevance
Project Narra+ve N/A